Novel approaches to improve comprehensive profiling of the epigenome and epitranscriptome

Project Summary
In 2022, advances from long-read sequencing methods facilitated the completion of a complete human
genome sequence. To interpret the genetic information from human genome sequences and understand how
cells regulate which parts of the genome are transcribed, how RNA transcripts are processed, and how these
processes are dysregulated in disease, it is critical to comprehensively profile the epigenome and
epitranscriptome. In the last project period, our group made significant advances in multiple areas developing
methods for epigenome and epitranscriptome profiling using long-read sequencing, particularly in
improvements to our computational method FLAIR (Full-Length Alternative Isoform analysis of RNA).
Integrating these methods in S. cerevisiae, we have uncovered novel RNA processing changes associated
with chromatin remodeling mutants. In our future work, we will further optimize our method to probe chromatin
accessibility with a membrane-permeable small molecule, which has the potential to facilitate epigenomic
studies in low-input tissue samples. We will use our insights and expertise gained from benchmarking and
evaluating long-read methods for transcript assembly to further advance the field of RNA modification detection
in order to directly profile full-length alternative RNA isoforms, RNA edits, and RNA modifications from single
RNA molecule sequences. By combining our approaches in long-read epigenetic and epitranscriptomic
methods developed in the last project period along with future methodological advances proposed here, we will
elucidate the mechanisms of RNA processing changes associated with chromatin remodeler mutants in
humans, where there is additional genome and RNA processing complexities compared to yeast. Long-read
epigenomic and epitranscriptomic methods developed in this work have numerous important applications to
the broader scientific community and we are committed to continuing to develop and share computational tools
and protocols that are well-documented and user-friendly to facilitate wide adoption.

Public health relevance
Project Narrative Comprehensive profiling of DNA and RNA molecules, including nucleotide modifications, is important for a complete understanding of how genes are normally regulated or dysregulated in disease. To this end, we are developing approaches using long-read sequencing technology to simultaneously detect in vivo genome-wide DNA modification and DNA accessibility and correlate changes with complete RNA sequences, along with RNA modifications. We will apply our approaches to uncover how epigenome regulation affects epitranscriptome regulation by suppressing expression of key epigenome modulators.